Clinical Protocol and Data Management (CPDM)

CLINICAL PROTOCOL AND DATA MANAGEMENT (CPDM): ABSTRACT
Part I: Clinical Protocol and Data Management (CPDM). Clinical research at the University of Arizona
Cancer Center (UACC) is supported by the UACC Clinical Trials Office (CTO), which functions as the UACC
Clinical and Protocol Data Management (CPDM) resource. The CTO staffing includes 79 FTEs to support
UACC investigators conducting both interventional and non-interventional cancer clinical trials. The CTO
supports Institutional, National Clinical Trials Network, Externally Peer-Reviewed, and Industry-sponsored
clinical trials, and provides comprehensive services for the entire trial lifecycle, including regulatory support,
data management, clinical research coordination, research nursing, training and education, and technology
services. The CTO uses a centralized clinical trials management system, OnCore, to manage protocol conduct
and to provide reports and performance metrics to the Cancer Center leadership. These metrics facilitate
oversight and strategic planning and support ongoing process improvement and training needs. In the current
project period, the CTO oversaw the activation of 327 interventional trials and 23 non-interventional trials. In
the same period, the CTO supported the accrual of 6,116 participants to interventional trials, 1,259 to
interventional treatment trials, and an additional 4,857 to non-interventional trials. This included the activation
of 71 new trials and the recruitment of 3,535 participants during the 2020 COVID-19 period (2,835 to
interventional accruals of which 342 were to interventional treatment trials and 700 to non-interventional trials).
Part II: Data and Safety Monitoring (DSM). All interventional trials are required to include a DSM plan. For
UACC-led interventional investigator-initiated trials (IITs), UACC’s DSM Board (DSMB) approves and executes
the DSM plan by performing risk-based monitoring to ensure the highest levels of patient safety under an NCI-
approved DMSB charter. In 2020, DSMB conducted 91 reviews that encompassed 48 serious adverse events
across 15 trials. There were no findings that prompted an audit or trial suspension.
Part III: Inclusion of Women and Minorities in Clinical Research. UACC actively promotes the
recruitment of women and minorities. In the current review period, 3,153 women and 2,780 members of
underrepresented minorities participated in clinical trials. In 2020, among the 2,835 individuals enrolled on
interventional studies, 54% were female, 35% identified as an ethnic minority (Hispanic), and 11% identified as
a racial minority. As a major new initiative, UACC is launching its Arizona Clinical Trials Network (ACTN) to
improve clinical trial access to underrepresented populations across the Catchment Area and the entire state.
Part IV: Inclusion of Individuals Across the Lifespan in Clinical Research. UACC complies with NIH policy
on the inclusion of individuals across the lifespan in research. In the review period, 46 participants under the
age of 20 and 651 over the age of 65 were enrolled on interventional treatment trials.